Biomarkers to stratify pain severity and type in pancreatic disease

PROJECT SUMMARY
Chronic pancreatitis (CP) results from progressive inflammation and fibrosis, most commonly from acute
pancreatitis (AP) and recurrent episodes of AP (RAP), and is associated with long term complications of diabetes
and exocrine pancreatic insufficiency. Pain is one of three diagnostic criteria for AP and multiple studies have
now confirmed that pain is also the most significant symptom for patients with CP (77-93%). While there
are a variety of interventions available to treat pain, many of which are not efficacious in CP patient: only ~25%
chronic pancreatitis patients achieve meaningful pain relief with current standard of care for pain
management. As of now, there are no chronic pancreatitis pain biomarkers to stratify pain based on severity
and/or type, which would guide physician decision making or monitor therapeutic responses. This contributes to
the immense burden of pain in this CP patient population.
To address this gap in knowledge, we will leverage the PROspective Evaluation of Chronic Pancreatitis for
EpidEmiologic and Translational StuDies (PROCEED) which has been realized under the auspice of the NIDDK-/
NCI-funded Consortium for the Study of Chronic Pancreatitis, Diabetes, and Pancreatic Cancer (CPDPC).
PROCEED, which will be a key resource for this proposal, is the first prospective longitudinal CP cohort in the
U.S. It has enrolled 1638 (and counting) participants with CP, AP, and RAP, as well as healthy and non-
pancreatitis symptomatic controls. All participants of this unique cohort undergo deep phenotyping, provide
detailed information on clinical symptoms, and general QoL variables. Furthermore, 10 pain-associated variables
are recorded providing detailed information about pain types, severities and interventions. Due to the size and
multi-site nature of PROCEED, the cohort was split into independent discovery and validation cohorts to enable
FDA-compliant biomarker validation. In Specific Aims 1 and 2 of this proposal, we will use plasma and urine
samples from the PROCEED discovery cohort (n >500) to generate quantitative multi-omics datasets of the
proteins, chemokines, cytokines and neuropeptides. Mass spectrometry-based discovery proteomics and
multiplexed antibody-based assays will be used for the biomarker identification.
Upon discovery of promising pain biomarkers, we will transition to the validation phase (Specific Aims 3 and 4).
In this phase, we will use the urine and plasma samples from the independent PROCEED validation cohort (n
>500) to validate the potential biomarkers identified in the Specific Aims 1 and 2. We will use targeted liquid
chromatography/mass spectrometry methods as well as antibody-based method for the validation. The large
number of PROCEED samples and their superb annotation will allow for an exquisitely granular pain-focused
analysis of the resulting large scale proteomic and cytokine/chemokine assay data.

Public health relevance
PROJECT NARRATIVE Most patients with chronic pancreatitis experience severely debilitating pain. Unfortunately, only ~25% of these chronic pancreatitis patients achieve meaningful pain relief with current standard of care for pain management, highlighting the urgent need for objective biomarkers to stratify pain type and pain severity. This proposal is designed to discover (Specific Aims 1 and 2) and validate (Specific Aims 3 and 4) such pain biomarkers in plasma and/or urine, which have the potential to significantly improve pain management for chronic pancreatitis patients so that the majority can enjoy a meaningful pain relief.